A BRAIN Initiative Resource: The Neuroscience Multi-omic Data Archive

The Brain Research through Advancing Innovative Neurotechnologies (BRAIN) Initiative
promotes the development and application of technologies to describe the temporal and spatial
dynamics of cell types and neural circuits in the brain. The Principal Investigator, senior
personnel and staff of this project have diverse expertise required to marshal data across the
BRAIN Initiative consortium, including experience in data collection from multiple institutions,
large-scale quality control and analysis processing capability, familiarity with NIH policy and
public archive deposition strategies. To promote smooth interactions across a large research
consortium, we will develop the Neuroscience Multi-Omic Archive (NeMO Archive), a data
repository that is specifically focused on the storage and dissemination of omic data from the
BRAIN Initiative and related brain research projects. We will utilize a federated model for data
storage such that the physical location of data can be distributed between the NeMO local file
system, public repositories, and a cloud-based storage system (e.g., Google Cloud Platform).
We will leverage this capability and distribute BRAIN Initiative data between our local filesystem
and the cloud. The Nemo Archive will be a data resource consistent with the principles
advanced by research community members who are launching resources in next generation
NIH data ecosystem. These practices include FAIR Principles, documentation of APIs, data-
indexing systems, workflow sharing, use of shareable software pipelines and storage on cloud-
based systems. The information incorporating into the NeMO archive will, in part, enable
understanding of 1) genomic regions associated with brain abnormalities and disease; 2)
transcription factor binding sites and other regulatory elements; 3) transcription activity; 4) levels
of cytosine modification; and 5) histone modification profiles and chromatin accessibility. It will
enable users to answer diverse questions of relevance to brain research, such as identifying
diagnostic candidates, predicting prognosis, selecting treatments, and testing hypotheses. It will
also provide the basic knowledge to guide the development and execution of predictive and
machine learning algorithms in the future.

Public health relevance
The Neuroscience Multi-Omic Archive (NeMO Archive) is a data repository that is specifically focused on the storage and dissemination of omic data from the BRAIN Initiative and related brain research projects.